MOLECULAR GENETICS OF SEXUAL DIMORPHISM

Many human behaviors and diseases are influenced by both heredity and the environment. We are seeking to identify and understand how individual genetic loci interactively contribute to a variety of complex traits including psychological characteristics, HIV progression, and cancer risk-related behaviors such as smoking and excess alcohol consumption.